Advanced Water Treatment System for On-Site PFAS Capture and Destruction

PROJECT SUMMARY
Per- and polyfluorinated alkyl substances (PFAS) comprise a class of thousands of toxic compounds that have
been found in drinking water sources in 34 US states and in the blood of 97% of people tested. Exposure to
PFAS has been linked to immune toxicity, cancer, high cholesterol, and several other health effects. More than
57,000 sites across the US are estimated to have PFAS pollution, and the total remediation market is estimated
at $160 billion. Adsorption technologies are widely used for removing PFAS from water sources, but these
produce secondary waste in the form of PFAS-laden spent sorbent media or complex regenerate solutions.
Disposal or incineration of this secondary waste is costly and becoming highly regulated or even banned in some
states. Enspired Solutions is commercializing a patented PFAS destruction technology called micelle-
accelerated photoactivated reductive defluorination (PRD). We are developing a micelle-accelerated PRD
reactor to degrade PFAS on spent ion exchange (IX) resin and regenerate the resin for further PFAS removal.
The commercial system is the size of two large refrigerators, fully automated and modular to accommodate site-
specific flow rates of 1,000 to 1,000,000 gallons per day of water contaminated with ng/L to µg/L concentrations
of PFAS. Treatment cost estimates are competitive with PFAS capture and disposal. Our proprietary chemical
formulation traps PFAS in solution inside a micelle, where an electron donor generates a hydrated electron upon
exposure to ultraviolet (UV) light. The hydrated electron breaks the carbon-fluorine bonds of PFAS molecules,
which degrades them to environmentally benign by-products. Compared to other PFAS destruction technologies,
micelle-accelerated PRD is more efficient, safer and requires a smaller footprint. When paired with suspended
spent IX resin, the positively charged resin surface can localize PFAS and our electron donor for selective PFAS
destruction. Any PFAS that desorbs from the resin will be captured in a micelle in solution and similarly degraded.
Bench scale micelle-accelerated PRD reactions will be performed on suspensions of IX resin loaded with PFAS
from a synthetic solution. Defluorination of PFAS will be monitored in real time as a function of UV dose and
confirmed with individual PFAS compound analysis. Reaction conditions will be optimized to achieve ≥ 99% (two
orders of magnitude) PFAS destruction. We will test the reusability of the resins after micelle-accelerated PRD
by measuring the adsorption capacity after regeneration, targeting 60 – 80 % capacity retention after each
regeneration cycle. In Phase II, we will test the reaction with a range of real PFAS-laden wastewater samples,
which will have complex matrices and a broader range of PFAS compounds. We will also expand testing to other
media used for PFAS adsorption (ionomers, biochar, modified cornstarch, etc.) and larger sample volumes. This
system will provide a complete, on-site PFAS capture plus destruction solution that will eliminate secondary
waste generation and put an end to the spread of PFAS.

Public health relevance
PROJECT NARRATIVE The widespread contamination of drinking and other water sources with per- and polyfluorinated alkyl substances (PFAS) represents an urgent public health issue due to adverse health effects associated with PFAS exposure. The current strategy of removal through adsorption or filtration does not fully address the problem and leads to further spread of PFAS in the environment. When paired with PFAS capture on adsorbents, the micelle- accelerated photoactivated reductive defluorination technology developed at Enspired Solutions can provide a safe, efficient and cost-effective approach for on-site PFAS capture and permanent destruction.